Human pulmonary neuroendocrine progenitors in lung injury and disease

PROJECT SUMMARY
Pulmonary neuroendocrine cells (NECs) are rare airway neuroepithelial cells with diverse sensory,
signaling, and stem cell functions. NECs have recently become one of the better studied rare cell types of the
mammalian lung, most notably through mouse studies. Ours and others’ single cell anatomical mapping, lineage
studies, and transcriptional profiling in mice have led to a rich understanding of their development molecular
diversity, and stem cell and airway repair function, and physiological studies show their function as specialized
sensors that modulate breathing. In contrast to this rich understanding of mouse NECs, little is known about
human NECs, including their anatomical distribution, structures, progenitor cell function, and response to airway
injury and role in repair. Because NE diseases originating from proximal airways have distinct clinical, histologic,
and molecular features from those found in the distal airways, we constructed a foundational cell resolution
anatomical map and generated initial molecular and proliferative profiles of human NECs to identify NE
progenitor cells within their ‘niches’, and to uncover the origin of diverse human NE proliferative disorders. We
have discovered extensive anatomical, histological, and molecular diversity in PNECs not modeled in mouse.
Using precision cut lung slice (PCLS) cultures from normal adult human lung, we find that a subset of healthy
adult human NECs proliferates in distal NEBs. This enables functional interrogation of these putative NE
progenitors (NEPr), which we propose to identify and characterize here. We hypothesize that human distal airway
NEBs harbor a specialized subset of molecularly and functionally distinct NE progenitors, and we predict human
progenitors are activated by airway injury and controlled by a similar mitogenic pathway as in mouse. Here, we
propose to use acute injury models to activate NEPr in human lung precision cut lung slice cultures and in whole
donor lungs to reveal their molecular profiles and their ‘niches’ by spatial transcriptomics. We predict NEPr are a
prominent source of human NE proliferative disorders and pathologies of the distal airways, such as diffuse
idiopathic pulmonary neuroendocrine cell hyperplasia (DIPNECH), which we propose to examine here by single
cell and spatial transcriptomics. Finally, we will identify the mitogenic pathway regulating distal human NEPr,
which could provide therapeutic target(s) for DIPNECH and other distal NEPr disorders. Identification and
characterization of NEPr in distal airways would establish a foundation for elucidating their roles in repair and
disease, and for creating human organoid and human induced pluripotent stem cell (iPSC) models that
accurately model distal human neuroendocrinopathies. This work also provides a strategy for identifying and
characterizing the NEPr and associated diseases in other regions of the human lung.

Public health relevance
PROJECT NARRATIVE Pulmonary neuroendocrine (NE) cells are activated by multiple stimuli, express diverse bioactive signals, and proliferate in response to injury with dysregulated proliferation associated with distinct histology and clinical features at different locations along the airway. The goal of this project is to determine the molecular diversity of human NE progenitors and their regulatory signals by investigating their activation in acute injury models, their diversity in human proliferative NE diseases, and identifying the signals that control their proliferation. This work generates foundational knowledge for diverse and poorly understood human respiratory conditions associated with proliferative disorders of the NE system.